Generating a multi-channel data framework for AI analysis in Radiation therapy

Following exhaustive data gap analysis of location, extent and usability of data streams, several have now been successfully aggregated and work is ongoing in particular with respect to imaging and radiation therapy data which are particularly siloed. The current goal is to gather data in robust manner that allows for a queriable and scalable format and then to develop AI methods for the curation and cleaning of data to create buildable infrastructure for robust data collection and harmonization of oncology patients.